Changing Talk Online Training (CHATO): A National Trial to Reduce Behavioral Symptoms in Long Term Care Residents with Alzheimer's Disease and Other Dementias

Project Abstract
The growing population of persons with dementia presents challenges to providing high quality nursing
home (NH) care. Care is complicated by behavioral and psychosocial symptoms of dementia (BPSD) such as
aggression, vocal outbursts, wandering, and withdrawal that occur as persons with dementia lose cognitive
and communication abilities and cannot verbally express unmet physical and psychosocial needs. NH staff
use “elderspeak,” speech similar to baby talk that is demeaning to residents. Residents react to elderspeak
with BPSD resulting in increased use of psychotropic medication to control BPSD, higher staffing needs, more
staff stress and turnover, and increased costs. The Changing Talk (CHAT) training program educates staff
about elderspeak and person-centered communication strategies and is proven to reduce staff elderspeak and
BPSD. The next step to increase the impact of this effective classroom-based training is to test CHAT content
provided in online internet modules. Providing this training online (CHATO) can improve access for busy staff
and those in rural and small NHs to increase dissemination across care settings to improve dementia care.
This continuing renewal study will test a new, online version of CHAT, a nonpharmacological
intervention that effectively decreases staff elderspeak communication and subsequently reduces BPSD in NH
residents with dementia. The interactive CHATO modules provide flexible access to training, continuously
accessible to staff via the internet. In this pragmatic trial, 120 NHs will be randomly assigned to CHATO training
or to the control group. BPSD and psychotropic medication rate data, extracted from the Center for Medicare
and Medicaid Services Nursing Home Compare and Minimum Data Set, will be compared using linear mixed
modeling. NH strategies used to engage staff (paid time to complete, recognition) and other supports will be
analyzed in relation to staff participation rates and changes in the outcome measures. Costs will be determined
in relation to changes in the outcomes and ongoing use and reinforcement of training will be assessed at a
one-year follow-up survey for participating nursing homes. The overall goal of this study is to prepare for large
scale dissemination and implementation of this evidence-based nonpharmacological intervention to reduce
RTC for residents with dementia across long term care settings.
This research addresses NIA's milestones for nonpharmacological dementia care interventions, NINR's
symptom management and caregiver support missions, the National Plan to Address Alzheimer's Disease goal
to enhance care quality and efficiency, and the Alzheimer's Association Plan to build a workforce with high-
quality care skills. Reducing inappropriate use of psychoactive medications to control BPSD is the top priority
goal of the National Partnership to Improve Dementia Care. As the number of persons with dementia triples in
the next 30 years, empowering care providers to provide high quality dementia care is of critical importance.

Public health relevance
Project Narrative The National Plan to Address Alzheimer's disease has identified education of dementia care providers as a top priority to address the need for quality care for the population of persons with dementia that will triple in the next 30 years. This study will test new online interactive training for nursing home staff that improves staff communication and also reduces behavioral symptoms of persons with dementia that they care for. Innovative approaches to reach care providers are essential to achieve implementation of evidence-based practices to improve care.